Novel Techniques for Evaluating and Assessing Symptoms, Affect. Heart Rhythm and Functional Status in Patients with Atrial Fibrillation: miAfib Project

Project Summary/Abstract
Atrial fibrillation (AF) is the most prevalent, major arrhythmia in the United States. It leads to an increased risk
of stroke, congestive heart failure, and overall mortality. AF is also characterized by symptoms in a majority of
patients that can result in significant decreases in health related quality of life and functional status, which are
strong predictors of all-cause and cardiovascular hospitalizations in patients with AF. Therefore, improvement
in symptoms is an important therapeutic goal in the management of patients with AF along with reducing the
risk of stroke and mortality. However, previous studies evaluating symptoms in AF have been limited by their
retrospective assessment of symptoms that limits our ability to assess the relationship between heart rhythm,
symptoms, affect and functional status in real time.
To address all of these gaps, we propose an innovative study that will intensively examine 100 patients with
paroxysmal AF using a continuous heart rhythm recorder and a novel mobile application to collect data on
symptom and affect ratings during multiple occasions across a day for three weeks. We will then be able to
examine the relationship between symptoms, affect, heart rhythm as well as additional features within the ECG
recording and assess their effect on functional status in patients with AF. We hypothesize that 1) some
symptoms will be much more specifically indicative of being in AF (e.g. palpitations) than others (e.g. fatigue)
2) ECG features derived from signal processing and machine learning algorithms (especially those that serve
as surrogates for autonomic function) will be more sensitive and specific for determining the presence and
severity of symptoms compared to average heart rate 3) there will be a strong relationship between affect, and
both symptoms and functional status .
The overarching goal of this proposal is for candidate (Hamid Ghanbari, MD, MPH) to develop an independent
research program examining symptoms and associated decline in functional status in patients with paroxysmal
AF. The candidate will build upon his previous training by partnering with a team of mentors who are experts in
ecological momentary assessment methodology, signal processing and machine learning, affect, and
functional status to acquire expertise in evaluation of repeated, real-time assessments of symptoms and to
explore novel ECG features that predict symptoms beyond the presence or absence of AF. In concert with the
proposed study, the candidate will also pursue didactic training and one-on-one mentoring related to his
research aims.
This proposal will more clearly characterize symptoms and their physiological and psychological correlates and
their subsequent influence on functional status in patients with AF. The insights obtained through this proposal
could eventually lead to individualized behavioral and medical interventions that best address these symptoms
and associated dysfunction.

Public health relevance
Project Narrative - Public Health Relevance Atrial fibrillation (AF) is the most prevalent arrhythmia in the United States and is associated with an increase in the risk of stroke, congestive heart failure and overall mortality. Despite the importance of AF, our understanding of symptoms associated with AF is limited by studies that rely on evaluation of symptoms based on a single clinical visit. The overarching goal of this proposal is to explore the complex relationship between symptoms, heart rhythm, and affect and assess their influence on day-to-day functioning using wearable sensors and a smartphone based mobile application.